Interplay between biological aging and neuropsychiatric phenotypes after trauma

PROJECT SUMMARY
Psychological trauma is often unavoidable and an established contributor to persistent neuropsychiatric
sequelae (PNS). Yet only a proportion of trauma-exposed persons are vulnerable to PNS, and the mechanisms
underlying this vulnerability are largely unknown. Trauma and related PNS have been associated with advanced
biological aging, measured with both molecular markers and brain imaging. Among molecular markers,
epigenomic markers (so-called “epigenetic aging”) combine DNA methylation (DNAm) at multiple age-related
genomic sites to predict disease outcomes. Complementarily, telomere shortening is another molecular marker
independently associated with aging and disease. The overall objective of this application is to determine the
extent to which molecular aging markers right after trauma and their changes over time predict and co-occur with
PNS trajectories and age-related brain alterations. The central hypothesis is that advanced molecular age
contributes to high risk for PNS and concomitant age-related alterations in brain function and structure after
trauma. The rationale for this application is that combining integrative assessments of molecular age with
longitudinal deep phenotyping and brain imaging data after trauma can yield novel predictors and insights to
guide interventions for promoting brain health and alleviating PNS across the age spectrum. The central
hypothesis will be tested with three specific aims: 1) Determine the extent to which integrative molecular aging
markers at the time of trauma predict PNS; 2) Uncover the temporal and genomic site-specific dynamics of
molecular age along PNS trajectories; 3) Define the functional and structural brain alterations dynamically
associated with molecular age after trauma. To this end, the application leverages established multi-ancestry
discovery and replication cohorts of women and men presenting to the emergency department (ED) right after
psychological trauma exposure. Participants have provided whole blood DNA at ED presentation and then were
followed with deep neuropsychiatric phenotyping, functional and structural brain imaging, and additional DNA
sampling over the ensuing 12 months. Leveraging this unique study design and already available DNA in both
cohorts, integrative molecular age will be longitudinally determined by measuring epigenetic aging and telomere
length. Moreover, longitudinal whole methylome sequencing (WMS) data will be generated in a cohort subset to
develop unbiased, novel epigenomic markers of aging in association with PNS. Lastly, key findings will be
generalized to non-ED settings using larger-scale DNAm data available in neuropsychiatric cases and trauma-
exposed controls from diverse military and civilian cohorts of the Psychiatric Genomics Consortium. This
research is innovative as it will assess molecular age at the time of trauma as a predictor of PNS, interrogate the
entire methylome with WMS, and integrate longitudinal molecular and phenotypic measures with brain imaging.
This work is significant as it can establish molecular age measured at ED presentation and other settings as a
novel predictor and potential treatment candidate for promoting brain health and alleviating trauma-related PNS.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as it is expected to open exciting research avenues and new horizons toward the development of personalized interventions that modulate biological age to benefit vulnerable trauma-exposed persons. These expected contributions are relevant to NIA’s mission as they will improve understanding of the biology of aging and its impact on trauma-related neuropsychiatric risk, ultimately promoting brain health and alleviating persistent neuropsychiatric sequelae across the age spectrum.